Neutralizing Circulating Histones With an RNA Aptamer to Prevent MultiorganDysfunction in Sepsis

Every year, sepsis affects more than 30 million people and is the primary cause of morbidity and mortality in
noncoronary intensive care units in the Western world. In the Veterans Affairs healthcare system, sepsis
hospitalizes over 35,000 Veterans annually. Patients with severe sepsis have mortality rates of 33% at 28
days and 71% at three years. The management of sepsis is mainly supportive while waiting for antibiotic
therapy to be effective. Recent evidence suggests that the molecular mechanisms responsible for organ
dysfunction associated with sepsis involve the release of nuclear proteins, of which histone proteins are the
most abundant. The applicant’s laboratory recently developed RNA aptamers that bind with high affinity and
specificity to human histones but not to other serum proteins. Administration of this selected RNA aptamer,
referred to as KU7, inhibited histone-induced platelet aggregation, Toll-like receptor activation, endothelial cell
death, and calcium influx in cultured cells. Preliminary data showed that KU7 protects against weight loss and
pulmonary edema and improves the survival of mice challenged with lipopolysaccharide endotoxins. As a
next step, studies are needed to test the efficacy of KU7 in an animal model of sepsis. The data derived from
this project will provide the necessary information for a competitive application for additional grant funding.
Experiments will test the hypothesis that the RNA aptamer KU7 reduces organ dysfunction and improves
survival in a murine model of sepsis. Aim 1 will establish the cecal slurry (CS) model of sepsis in mice in the
applicant’s laboratory. The severity of sepsis will be titrated to allow subsequent experiments to study illness
severity and mortality. Serum histone levels will be measured at different time points after the CS injection to
identify the optimal timing of the initial dose of KU7. Aim 2 will determine the efficacy of KU7 in improving
survival and illness severity in sepsis. As sepsis is associated with the release of bacterial nucleases, the
effectiveness of two different chemical modifications of KU7 will be compared. These studies will also identify
the minimum and maximum effective dose of KU7, determine whether KU7 provides additional benefits to
antibiotic therapy, and compare KU7 with a previously described neutralizing histone antibody. Aim 3 will
perform a series of biochemical and histological analyses to assess the efficacy of KU7 in protecting against
organ dysfunction in sepsis. The significance of this project is supported by the prevalence and complications
of sepsis and the absence of FDA-approved therapies to prevent histone-mediated tissue injury. The
innovative strength of this proposal is the identification of novel therapeutic bioreagents that, if successful,
would change the paradigm of treatment of critically ill patients with sepsis. As therapeutics, aptamers will not
have the same limitations as other biologics and will provide rapid and easy delivery with the potential to save
lives.

Public health relevance
Sepsis results from severe bacterial infections and is the leading cause of organ damage and death in noncardiac intensive care units. Over 35,000 Veterans are hospitalized for sepsis each year. Unfortunately, the treatment of sepsis remains largely supportive while waiting for antibiotic therapy to be effective. During sepsis, histone proteins are released from cells and cause tissue damage. We developed a biodrug (aptamer) that binds histone proteins to prevent them from having toxic effects. We showed that this aptamer can protect against histone-mediated damage in cultured cells and mice. In this application, we propose extending these studies to test whether aptamers protect against sepsis-induced organ dysfunction and death. If successful, these data will support the expansion of our studies to larger animals, with the goal of eventually providing a novel, effective treatment of sepsis in Veterans.